Xavier University of Louisiana Driving Advancement Transforming Access (XULA DATA)

The All of Us Research Program (AoURP), also known as the Precision Medicine Initiative, is a longitudinal study seeking to enroll one million participants as diverse as the nation. Specifically, the Program seeks to enroll people who have not typically participated in biomedical research. The AoURP will have the tools to evaluate three dimensions of health: biology, environment, and lifestyle. One of the priorities of the AoURP is to engage and mobilize AoU Workbench Researchers to productively use this research asset to address health concerns that impact the lives of citizens. The Xavier University of Louisiana Driving Advancement, Transforming Access (XULA DATA) Program seeks to engage, educate, and equip faculty and student researchers from high teaching load and high advising load (HTL/HAL) intuitions to be able to participate in Big Data research by productively using the AoU dataset

Public health relevance
No PHR